Investigation of Dpp9 in COVID19

Project Summary
To better understand the determinants of severe COVID19, we have focused on the inflammasome regulatory
protein DPP9. GWAS have implicated DPP9 in poor outcomes in COVID19 and in the development of idiopathic
pulmonary fibrosis. DPP9 and closely related DPP8 serve as endogenous inhibitors of the viral inflammasome
sensors NLRP1 and CARD8. This pathway is activated by diverse mechanisms of pathogen sensing which
include detection of viral encoded proteases, bacterial E3 ubiquitin ligases and direct sensing of viral dsRNA.
Our preliminary data indicate that this pathway is transcriptionally upregulated in human myeloid cells in
response to SARS-CoV-2, a stimulus which activates the inflammasome. We have also discovered that mice
which lack Dpp8 and Dpp9 have dysregulated T cell responses and develop more severe disease when
challenged with SARS-CoV-2. Our ongoing work seeks to better understand 1) the immunological differences
conferred by the COVID19 risk allele rs2109069 “A” located within a DPP9 intronic region, 2) the basis for T cell
dysregulation in our novel mouse model and 3) how T cell dysfunction influences disease severity in response
to SARS-CoV-2 infection.

Public health relevance
Project Narrative: We aim to elucidate the immunological basis of why otherwise healthy individuals develop severe COVID19 by studying the role of DPP9. Human genetics have highlighted the importance of DPP9 in response to SARS-CoV-2 infection, and our preliminary studies indicate this role is conserved in mice. We are therefore uniquely situated to determine how this susceptibility locus determines disease outcome to one of the biggest global health challenges in the last century.